Multi-release drug-coated balloons for the treatment of peripheral artery disease with long, diffuse, and multiple lesions

Project Summary/Abstract Peripheral artery disease (PAD) affects over 200 million people worldwide and can result in life-threating complications. Currently, drug-coated balloons (DCBs) are used to treat lesions in the peripheral arteries. However, commercially available DCBs are designed to treat only a single blockage site. In PAD patients, complex lesions involving long, diffuse, and/or multiple blockages are often found resulting in the use of multiple DCBs. With each DCB being very expensive and the procedure time consuming, there is a need in the market for a multiple-release DCB that can release the drug at multiple arterial locations which can reduce the number of DCBs needed for a procedure. This will ultimately result in the reduction of cost, time, and complications of DCB procedures involving complex lesions. A single release DCB was recently developed by Tailored Medical Devices, Inc. using polyethylene oxide (PEO) as a platform to control the release of the drug paclitaxel (PAT). The developed PEO balloon has shown to be safe and effective in a pre-clinical setting for the treatment of a single blockage. With modifications in the single-release PEO balloon formulation and coating strategy, a multiple-release PEO DCB (MR-PEO- DCB) has been developed. A recent pilot study showed that equivalent drug uptake and retention can be achieved in two arteries using a MR-PEO DCB. The goal of this project is to develop a sterile and biocompatible MR-PEO-DCB that can deliver PAT for the treatment of complex lesions and investigate the reproducibility of the drug retention in two different arterial locations for up to 7 days using a porcine model. Specific Aim 1: Develop reproducible and sterile MR-PEO-DCBs in a cGMP facility The MR-PEO-DCBs will be developed in a GMP facility through the use of sterile instruments and solutions used to produce the formulations. The physical, thermal, chemical, and drug-release properties of the MR- PEO-DCB coating will be tested using imaging, calorimetric techniques, and an established in vitro flow model. The developed devices will then be tested for sterility according to established USP testing methods. Specific Aim 2: Test the cytotoxicity and hemocompatibility of the MR-PEO-DCB The cytotoxicity and hemocompatibility testing will be conducted as per the FDA guidelines for the short exposure (< 24 h) blood circulation devices. Cyotoxicity, hemolysis, and complement activation will be assessed by the exposure of the device or its extracts to the appropriate cell lines. Specific Aim 3: Test the drug retention and plasma drug levels after MR-PEO-DCB treatments in vivo In vivo swine studies will be performed to test the reproducibility of drug retention at day-1 and day-7. A successful outcome of this proposal will be to develop a sterile and biocompatible multiple-release DCB that can obtain therapeutic and equivalent amounts of drug in two arterial locations. Future phase II studies would include long-term animal studies on tissue retention and healing responses.

Public health relevance
Project Narrative Peripheral artery disease is frequently associated with complex lesions including long, diffuse, and/or multiple blockages that currently requires the use of two or more drug-coated balloons (DCBs) for treatment. We have identified a formulation and coating strategies that allows for a safe and effective treatment of these lesions. In this project, we propose to develop a multi- release DCB that will be able to treat these complex lesions with the use of a single DCB to provide a safer, cheaper, and less complicated alternative to the currently used methods.